Functional Mapping of Translation Initiation Kinetics to Quantify the Protein-Coding Capacity of the Human Genome

PROJECT SUMMARY
Despite their central role in protein synthesis, the rates of ribosomal initiation kinetics on different mRNAs and
across various tissues remain largely unknown. Understanding the cellular regulation of initiation kinetics and its
dysregulation in diseases can significantly enhance our fundamental knowledge of cellular biology and improve
modern therapeutics. However, the lack of methods to directly measure initiation across cell types, combined
with the vast mRNA sequence space and the complex, cell-specific interactions it supports, results in an
intractable complexity. This hinders our ability to answer several central questions, including: 1) How to predict
transaltion initiation rates from mRNA sequence? 2) How do initiation rates of individual mRNAs vary between
cell types? 3) To what extent does initiation rate determine protein levels in cells? 4) What are the initiation rates
at alternative and small ORFs translation initiation sites, and what is the protein encoding capacity of the genome?
This proposal outlines a five-year research plan to address these challenges and questions by developing a
measurement system that will measure the kinetic parameters that control translation initiation. These paramters
will be measured using a cell-free system reconstituted from cell-specific proteomes, which will be titrated with
large mRNA libraries, and followed by ribosome footprinting and sequencing-based quantification of ribosomes
locked on start codons. This functional genomics platform, termed MIT-seq, was recently developed by us
for bacteria and this proposal will adapt to human cells. It will be benchmarked using mRNA libraries
includes the entire human transcriptiome and compared to other, massively parallel reporter assays and existing
data from the litrature (Aim 1). Subsequently, we will measure the initiation affinities unprecedently large (1010)
mRNA libraries to explore variations in initiation kinetics between differentiated cells, such as kidney cells and
neurons (Aim 2). Finally, we will examine shifting landscapes and dysregulation of intiation kinetics and their
functional consequences between healthy and diseased cells using Fragile X Syndrome, a disease caused by
altered levels of the translation initiation regulator FMR1 protein, as a model (Aim 3).
To achieve these aims, the candidate will leverage his unique expertise in the molecular biology of translation
initiation developed during his PhD studies and the assays developed during his current postdoctoral fellowship
at MIT. To transition from bacterial systems to the molecular biology of human cells, the candidate has
assembled an outstanding advisory team, including relevant experts who have agreed to mentor, collaborate,
and provide resources for the project's success during its training phase (K99). Upon establishing Aim 1, the
candidate will pursue an independent career (R00) focusing on Aims 2 and 3, while working towards the long-
term goal of developing functional genomics tools and understanding the design principles, mechanisms, and
evolution of mRNA translation initiation across tissues and organisms.

Public health relevance
PROJECT NARRATIVE Translation initiation of ribosomes on mRNAs is central to gene expression regulation, but our quantitative understanding of how specific mRNA sequences affect this process is limited. This research proposal aims to bridge this gap by creating an initiation rate atlas. We will develop a functional genomics platform to directly measure translation initiation across the entire transcriptome, and unprecedently large synthetic mRNAs libraries, in multiple human cell types.